Identifying novel pathways targeting endothelial-to-mesenchymal transition during heart failure

PROJECT SUMMARY
Myocardial infarction (MI) alone causes 1 of every 7 deaths in the United States. As the heart has little regen-
erative capacity after injury, there is an urgent need for novel therapeutic approaches to MI. Improving myo-
cardial repair after MI will require enhancing vascular supply to regions with marginal perfusion and stimulating
myocardial regeneration through formation of new cardiomyocytes and supporting vasculature. Endothelial-to-
mesenchymal transition (EndoMT) plays a key role in embryonic development and in adult cardiovascular dis-
eases (CVDs). While several studies have shown the importance of EndoMT in heart failure (HF), our overall
knowledge of this process remains in its infancy in part due to the lack of mechanistic insight by which EndoMT
genes are regulated and the absence of definitive studies using specific tools to establish the role of EndoMT
in adult HF. The goal of this proposal is to leverage novel discoveries made by our group to define the role of a
new microRNA (miR) regulatory mechanism of EndoMT in MI, with an ultimate view to clinical translation. Be-
ta-arrestin (beta-arr)-biased beta2-adrenergic receptor (beta2AR) signaling in the heart elicits cardioprotection
and may underlie the beneficial effects of the betaAR antagonist (beta-blocker) carvedilol (Carv). We recently
discovered that Carv, acting through this mechanism, promotes the maturation of miR-532-5p (miR-532),
which plays a vital cardioprotective role. MiR-532 induces cardiac endothelial cell (CEC) function and neovas-
cularization after MI, and represses protease serine 23 (prss23; a key initiator of EndoMT, and a direct and
functional target of miR-532 in CECs). Interestingly, the expression of miR-532 is significantly enriched in
CECs and selectively downregulated in CECs isolated from ischemic myocardium, which is inversely associat-
ed with the expression of prss23. Thus, a greater understanding of miR-532-mediated cardiac protection, and
establishing the importance of increased miR-532 to the outcome of EndoMT and cardiac function might lead
to the development of novel effective therapies (eg. beta2AR-selective beta-arr biased ligands) for numerous
CVDs. Our hypothesis is that beta2AR/beta-arr-mediated activation of miR-532 maturation and function in ECs
results in beneficial adaptive remodeling in infarcted hearts by repressing prss23 and EndoMT. To test our hy-
pothesis, we plan to pursue three aims: 1) determine the contribution of miR-532 expression in ECs to post-
ischemic heart remodeling, 2) elucidate the role of prss23, a novel direct and functional CEC target of miR-532
in MI, and (3) investigate the impact of beta-arr-biased agonism of beta2AR on CEC and heart function modu-
lated by the miR-532/prss23 axis. This proposal is innovative because the role of the beta2AR/beta-arr/miR-
532/prss23 axis in EndoMT-related cardiac pathologies has never been studied, and proposed EC-specific
miR-532 conditional knockout (KO) and prss23 KO mouse models are entirely novel. This project is also signif-
icant because the crosstalk between beta2AR/beta-arr signaling and miR-532/prss23 axis can be exploited as
a novel target for studying underlying mechanisms and treatment of organ fibrosis mediated by EndoMT.

Public health relevance
PROJECT NARRATIVE Heart failure is a major cause of morbidity and mortality in the elderly, with expected increase in societal costs due to the aging population. The proposed study is relevant to the public health goal to develop strategies for primary prevention and innovative treatment because the discovery of a novel microRNA/target pair regulated by beta-arrestin-biased beta2-adrenergic receptor cardioprotective signaling is expected to increase understanding of endothelial-to-mesenchymal transition-related cardiac pathologies that are associated with dysfunction within this newly identified microRNA regulatory mechanism, which will be ultimately amenable for pharmacological manipulation. The proposed research is also relevant to the part of NIH's mission that pertains to developing fundamental knowledge that will help reduce the burdens of human heart disease.